A Novel Therapeutic to Promote Corneal Repair

The cornea is one of the most important tissues in the eye and its transparency is critical for good visual function
in humans. Corneal tissue injuries are the most common, everyday issue for practicing ophthalmologists and
can run the gamut in severity. Healing of large corneal wounds, such as alkali burns, involves extended migration
of epithelial cells as well as reinnervation of the cornea. However, complications from injury induced inflammation
slows these processes and worsens outcomes. The inability to seal and reinnervate the corneal epithelium
results in persisting inflammation and increases the risk for corneal ulceration. As strategies for wound care
have evolved, most innovation has continued to focus on minimizing inflammation. These approaches are
important for coaxing cells to migrate and heal the corneal epithelium, but do little for remodeling and repair of
the tissue, resulting in weakly attached tissue and slow healing. Thus, to improve patient outcomes there is a
need for a safe and effective therapy that both expedites migration and reinnervation soon after injury and results
in a more efficiently closed and effectively matured wound. Ideally, mechanisms that deliver factors to
enhance corneal wound healing would be safe, applied topically, remain localized at the site of
application, and provide a rapid but sustained release of the active reagent.
Fidgetin-like 2 (FL2) is a recently discovered regulator of the microtubule cytoskeleton that severs and
depolymerizes microtubules (MT). Down-regulation of FL2 expression enhanced MT function to promote cell
motility in vitro and improved healing both clinically and histologically in murine animal models. MicroCures
aims to develop nanoparticle encapsulated FL2-siRNA (SiFi2) to directly enhance the wound-closure and
healing function of corneal epithelial cells as well as reinnervation thereby offering the potential for
accelerated healing and tissue repair in corneal wounds. Thus, wound healing would reduce scarring and
pain, improve vision, and lower the risk of infection due to faster wound closure, as well as improve restoration
of corneal architecture.
In proof of principle work, the optimal concentration of SiFi2 was determined in a rat model resulting in a shorter
time to re-epithelialization, reduced corneal opacity, and restoration of anatomical corneal structure, with no
evidence of nerve damage or apoptosis. This Fast Track Phase II proposal will initiate steps towards an IND
filing, including defining the formulation to be used. This will be accomplished over four specific aims: (1) develop
a SiFi2 formulation using an ex vivo based assay; (2) evaluate toxicity in a rabbit ocular tolerability model; and
(3) verify efficacy in a rabbit model of corneal burn; and (4) hold a pre-IND meeting with the FDA.

Public health relevance
Corneal injury is one of the most common causes for ocular related hospital visits, giving rise to tissue scarring and corneal haze, as well as reducing visual acuity . At present there is no clinically proven treatment to improve corneal wound healing and reinnervation. Our goal is to develop and bring to the market a novel therapeutic that stimulates wound healing and reinnervation in the cornea to treat corneal burns via RNAi-mediated silencing of the microtubule regulatory protein, Fidgetin-Like 2 (FL2).